Development of Apo Mimetic Peptides for the Treatment Cardiovascular Disease

The 5A amphipathic peptide, which was shown earlier by our laboratory to be specific for removing cholesterol by the ABCA1 transporter, was tested in a mouse model of atherosclerosis and was found to be protective (ref. 1). In a rabbit vascular collar model, it was found to reduce inflammation (ref. 4). In collaboration with Dr. Stewart Levine, we showed in a mouse model of asthma, it also reduced inflammation associated with asthma (J Immunol 2011;86:576). In the past year, we have also developed new single helical peptides containing a hydrocarbon staple that enhanced the cholesterol efflux potential of these peptides and made them resistant to gastric and intestinal proteolysis, thus potentially making these peptides orally available (BBRC 2011:10:446). The 5A peptide was licensed to an outside company for further drug development.